Imaging Biomarkers of Neurotoxicity in Welders

Abstract
Manganese (Mn) is an established neurotoxicant that affects the same motor and cognitive brain pathways
affected in Parkinson disease (PD), notably the nigrostriatal system. A large body of research, largely from our
collaborative team, demonstrates that Mn-exposed workers have a clinical phenotype which overlaps
substantially with PD, including Mn-dose-dependent progressive parkinsonism and nigrostriatal dysfunction on
positron emission tomography (PET) brain imaging. In the first five years of the present PET imaging project,
we used PET biomarkers of the dopaminergic system in the brain to establish that Mn-exposed workers had
lower caudate binding of the PET radioligand 6-[18F]fluoro-L-dopa (FDOPA), as compared to non-exposed
workers. These differences remained over five years of follow-up. We also found Mn-dose-dependent
upregulation of dopamine type 2 receptor (D2R) binding, as measured by the radioligand [11C](N-
methyl)benperidol (NMB), in the substantia nigra, the same region of the brain most dramatically affected in
PD. In addition, we found an inverse Mn-dose-response association with thalamic (i.e., extrastriatal)
[11C]dihydrotetrabenazine (DTBZ) binding, as well as a decline in DTBZ binding in caudate, putamen, and
substantia nigra over time. More recently, our lab found evidence of Mn-induced neuroinflammation (microglial
activation) in the brains of deceased Mn miners providing a potential mechanism for the in vivo findings in our
welder cohort. This renewal builds on our previous studies by exploring the role of neuroinflammation in Mn-
induced dopaminergic neurotoxicity. Our hypothesis is that Mn-induced progressive parkinsonism is a
neurodegenerative disorder and is due to Mn-dose-dependent dopaminergic degeneration. We will perform
repeat DTBZ and NMB PET imaging in research participants from our longitudinal Mn-exposed worker cohort
who have already undergone baseline DTBZ and NMB scans to investigate the association between lifetime
cumulative Mn exposure, informed by state-of-the-art neutron activated bone Mn quantication, and annual rate
of change in DTBZ and NMB binding. We will also perform N-acetyl-N-(2-[(11)C]methoxybenzyl)-2-phenoxy-5-
pyridinamine [(11)C]PBR28 (PBR28) PET imaging in these workers to characterize patterns of microglial
activation in the same brain regions, and investigate the relationship between lifetime cumulative Mn exposure
and PBR28 binding as a marker of neuroinflammation. We then will explore the role of neuroinflammation as a
mediator of Mn-induced striatal degeneration. Finally, we enlarge our cohort to enrich for active workers and
will perform longitudinal PET imaging to characterize the relation between lifetime cumulative Mn exposure and
the annual rate of change in both striatal and extrastriatal binding/uptake of these radioligands between active
and retired Mn-exposed workers. Successful completion of these aims will provide a unique opportunity to
understand the mechanism of an important environmental nigrostriatal neurotoxicant and potentially inform the
understanding of the environmental pathogenesis of PD.

Public health relevance
Project Narrative Manganese (Mn) is an established neurotoxicant that affects the same motor and cognitive brain pathways affected in Parkinson disease (PD), notably the nigrostriatal system. In this renewal, we will use positron emission tomography (PET) brain imaging to investigate the role of Mn in degeneration of the dopaminergic system and the potential neuroinflammatory mechanism. Successful completion of these aims will provide a unique opportunity to understand the mechanism of an important environmental neurotoxicant that targets the nigrostriatal brain pathway, which is the same pathway affected in PD.